HPV in the Context of Mens Health Disparities

PROJECT ABSTRACT/SUMMARY The Supplement to Promote Diversity in Health-Related Research (PA-21-071) is being requested on a R01-type behavioral research project under the funded Research Centers in Minority Institutions (RCMI-U54) at the University of Texas at El Paso (UTEP). The current research project under the RCMI is using a community-based participatory research (CBPR) approach to explore the attitudes, knowledge, and perspectives surrounding the human papillomavirus (HPV) and HPV vaccine among adults in the El Paso, TX region. However, preliminary analysis of current project efforts have demonstrated a low and non-representative participation from Hispanic males,requiring expertise in men’s sexual health: Dr. Jacob Martinez (candidate). As Dr. Martinez tackles the pertinent work surrounding men’s sexual health disparities in the El Paso- TX context—a Hispanic-majority, medically underserved, and health professional shortage U.S.-Mexico border community—he will receive guidance and mentorship from a cadre of interdisciplinary disparities researchers from Medical Anthropology, Social Work, Nursing, and Interdisciplinary Health Sciences. The R01-type HPV behavioral research project team and Dr. Martinez are requesting a long-term appointment on the PA-21-071 supplement as an Early Stage Investigator underrepresented in the Nursing and Academia as a Hispanic Male from a disadvantaged background. During the long-term candidate appointment, Dr. Martinez will (1) enhance his research capabilities in order to (2) achieve benchmarks of the male-specific health disparities research in the El Paso, TX region, and (3) will disseminate findings under the guidance and mentorship of a team of health disparities experts in order to reach research independence and diversify the research workforce.

Public health relevance
PROJECT NARRATIVE An R01-type behavioral research project under the funded Research Centers in Minority Institutions (RCMI-U54) at the University of Texas at El Paso (UTEP) is currently exploring the attitudes, knowledge, and perspectives of the human papillomavirus (HPV) and HPV vaccine among adults via a community-based participatory research approach; however, preliminary analysis have demonstrated a low and non-representative participation from Hispanic males, requiring expertise in men’s sexual health: Dr. Jacob Martinez (candidate). As Dr. Martinez tackles the pertinent work surrounding men’s sexual health disparities in the El Paso-TX context—a Hispanic-majority, medically underserved U.S.-Mexico border community—he will receive guidance and mentorship from a cadre of interdisciplinary researchers from Medical Anthropology, Social Work, Nursing, and Interdisciplinary Health Sciences. Within the long-term appointment as an Early Stage Investigator underrepresented in the Nursing and Academia as a Hispanic Male from a disadvantaged background, Dr. Martinez will (1) enhance his research capabilities in order to (2) achieve benchmarks of the male-specific health disparities research, and (3) will disseminate findings under the guidance and mentorship of a team of health disparities researchers in order to reach research independence and diversify the research workforce.